BID Core

The goal of the Behavioral Intervention Development Core (BID Core) is to conduct innovative pilot research
aligned with the goals of the NIA Roybal Centers for Translational Research on Aging and with scientific
direction provided by the External Advisory Committee (EAC). We will support pilot studies in Stages 0-IV of
the NIH Stage Model for behavior change, focusing on Stage IA pilots to modify, adapt, and refine existing
interventions and Stage IB feasibility pilots, and will advance to later stages as appropriate. Pilot testing will be
concentrated in our thematic focus areas for this funding announcement including Utilizing Behavioral
Economic Approaches to Improve Individual Behavior and/or Institutional Processes, Targeting Mechanisms of
Behavior Change Common to Multiple Health Behaviors, Leveraging Technology to Ensure Fidelity and/or
Scalability, and Promoting Adherence and Maintenance of Long-term Behavior Change. In addition, our pilots
will leverage human-centered design to improve the user experience, deploy technology platforms that
facilitate testing ideas at scale, and use artificial intelligence (AI)-informed dynamic adaptation to improve the
effectiveness of interventions under resource constraints.
The primary aim of the BID Core is to support mechanistically-grounded pilot projects with the potential—
through rigorous design, refinement, and feasibility testing, followed by efficacy and effectiveness testing—to
translate ideas from behavioral economics into practice and to improve health among middle-aged and older
Americans with modifiable risk for morbidity and mortality. We will prioritize the mentorship and training of
junior faculty and trainees, interaction between investigators at Penn and other universities, and the building of
effective collaborations with organizations that can translate research finding into results at scale.
In addition to the pilots supported through this proposal, we will continue to utilize other sources of support,
including federal and private sources, to advance a broader portfolio of research of high relevance to the
Roybal mission. Our BID Core will emphasize pilots that advance us towards success in bridging the efficacy-
to-effectiveness gap and solving for scale. We will also leverage the three strategic foci of our proposal:
design thinking, digital platforms, and dynamic adaptation. Our strategic foci will inform all funded pilots,
and will increase our ability to engage diverse populations, to do so at scale, and to “learn as we go” for rapid
and relevant results.

Public health relevance
The goal of our proposed Roybal Center is to speed up the pace and increase the impact of scientific discoveries about how to change health behaviors to prevent premature aging. To do this, we focus on three innovative strategies: design thinking to incorporate the experiences of older adults; online platforms that help us conduct large-scale studies easily; and dynamic adaptation, which allows us quickly learn how different interventions work for different populations. With these strategies, we will design and conduct studies ranging from small pilots to ensure our interventions can work up to larger-scale studies with companies and health care organizations that show how interventions do work in real-world settings.